Media services for National Eye Institute (NEI) results dissemination

The purpose of this task is to provide media services for activities related to reporting research results and other NEI dissemination activities.